Multiplex imaging in therapy refractory tumors: understanding the spatiotemporal facets of an immunosuppressive environment

immunomodulatory therapies. Although these breakthroughs unleash the immune system and can be
deadly to tumors, there are a high percentage of cancers that fail to respond. One complicating aspect is
tumor heterogeneity, both within the same cancer type and within a single patient. This aspect is
especially prominent in pancreatic adenocarcinoma (PDA), which is notoriously resistant to many frontline
immunotherapies and has a low 5-year survival rate. Although mouse models have made research into
PDA more accessible, these models frequently fail to capture the spectrum of tumor heterogeneity in
human PDA. Innovation. To address this limitation, I will use a unique collection of mouse pancreatic
tumor clones with distinct and reproducible responses to treatment, mimicking the tumor heterogeneity
seen in the clinic. This will provide me with unparalleled comparative and combinatorial power to
interrogate the tumor microenvironment. Additionally, my proposed experimental approach will leverage
emerging high-content imaging methods that are able to reveal the phenotype, activity, and spatial
organization of the tumor microenvironment in situ.

Public health relevance
PROJECT NARRATIVE Pancreatic cancer is an aggressive and therapeutically difficult cancer to treat. Mouse models of pancreatic cancer are therefore paramount to our mechanistic understanding of tumor microenvironment dynamics and immunomodulatory interventions. The overall goal of this research is to use cutting-edge microscopy techniques to mechanistically understand the fine grain cellular interactions that dictate tumor responsiveness and leverage them to improve synergistic therapeutic strategies.